Toxicity and Detoxification of Imidacloprid in the Murine Ovary

7. PROJECT SUMMARY
Neonicotinoids are synthetic nicotine derivatives that act as systemic neurotoxicants. They are used in
large-scale agricultural systems, in private home gardens, and as veterinary pharmaceuticals. The use of
neonicotinoid insecticides is rapidly increasing as they continue to replace known dangerous organophosphate
and methylcarbamate insecticides. Their ubiquitous and rapidly increasing use results in chronic exposure of
non-target species including humans, fish, birds, and pollinators. Despite their rising popularity, the literature is
devoid of studies that evaluate neonicotinoid toxicity in non-target species, especially regarding reproductive
function. Imidacloprid and two metabolites have been identified in the rat ovary 6 hours post dosing and reach
peak concentrations at 12 hours post dosing. It is unknown whether these metabolites reach the ovary via the
vasculature or whether the ovary has the metabolic machinery to metabolize the parent compound. Some
negative effects of imidacloprid on the ovary have been demonstrated in vivo including morphological
abnormalities of ovarian follicles, changes in plasma hormone concentrations, and evidence of oxidative stress
in ovarian cells. Beyond these pathologic endpoints, little is known about the mechanisms through which IMI or
its metabolites cause ovarian toxicity. The proposed work will test the hypothesis that imidacloprid causes
ovarian follicle toxicity via acetylcholine pathways and the ovary itself contributes to this ovotoxicity using its
metabolic machinery. Aim 1 will characterize the toxic endpoints of imidacloprid and relevant imidacloprid
metabolites through changes in gene expression and steroidogenesis in ovarian follicles in vitro. Aim 2 will
determine whether the ovary has the metabolic machinery to metabolize imidacloprid. Aim 3 will determine the
role that acetylcholine pathways play in imidacloprid-induced ovarian toxicity. Collectively these experiments will
provide a comprehensive overview of the effects of imidacloprid and its metabolites on both immature and mature
ovaries, with a focus on mechanism and the identification of ovarian metabolic machinery and acetylcholine
pathways. Through the completion of these experiments and other actives outlined in the research training plan,
the applicant will learn state of the art research techniques, develop technical writing skills, and create a strong
network of reproductive biologists, toxicologists, and veterinary clinicians.

Public health relevance
8. PROJECT NARRATIVE Imidacloprid is a small and relatively water-soluble pesticide with high likelihood of environmental accumulation and chronic exposure of non-target species such as humans. The proposed research project will investigate the mechanisms of toxicity and detoxification of imidacloprid in immature and mature mammalian ovaries as well as characterize novel drug targets within the ovaries such as metabolic enzymes and acetylcholine receptors. The public health outcomes of this work include identification of possible reproductive toxicants and development of methods to prevent or treat pesticide-induced reproductive problems.